Impact of AIM2 on Intestinal Stem Cell Differentiation During Inflammation

PROJECT SUMMARY/ABSTRACT
The mammalian intestine represents one of the most complex and immunologically-relevant organ systems. This
is due to its heterogenous mixture of epithelial cells that constantly interact with the trillions of microbes
comprising the intestinal microbiota and the underlying immune cells that inhabit the lamina propria. It is well
accepted that host-microbiota interactions at these mucosal sites are critical to localized and systemic immune
development, and disruptions in these interactions are associated with several chronic inflammatory diseases
like inflammatory bowel diseases (IBD). Yet, there is still much we do not understand about how the
communication networks between microbes, epithelial barriers and immune cells dictate the balance between
productive immunity and immune tolerance. Several mammalian pattern recognition receptors (PRRs)
expressed by immune cells and intestinal epithelial cells have been implicated in linking microbe-epithelial-
immune interactions during the regulation of IBD, with mutations in NOD2 being heavily associated with human
Crohn’s disease. Additional PRRs provide protective effects during animal models of experimental IBD, including
members of the NOD-like receptors (NLRs) and related DNA sensor Absent in Melanoma 2 (AIM2) through
formation of a multi-protein complex called the “inflammasome” and other non-inflammasome-mediated
functions. We have evidence that AIM2 is also critical to the development of specialized intestinal epithelial cells
called tuft cells, which initiate type 2 innate immunity in the small intestine. Tuft cell-driven type 2 immunity can
counteract the pathological Th1/17 immune responses that are hallmarks of many forms of IBD. However, the
molecular and cellular processes by which AIM2 accomplish this function is completely unknown. These
questions will be addressed using tissue-specific animals models of AIM2 deletion, intestinal epithelial organoid
models and experimental models of small intestine inflammation. The successful completion of this project will
lead to the identification of novel innate immune targets, cellular signaling pathways and microbial triggers that
can redirect immune activation, thus revealing new intervention points to promote IBD resolution.

Public health relevance
PROJECT NARRATIVE Although inflammatory bowel diseases are tightly linked to exaggerated immune activation, epithelial defects and disruptions in the microbes that reside in the gut, the anti-inflammatory factors that connect these distinct factors are still under intense investigation. This proposal will explore the impact of the microbial sensor AIM2 on epithelial cell communication networks that regulate inflammatory responses in the intestine. A better understanding of the negative regulators of intestinal inflammation will provide better insights into developing personalized strategies for preventing and treating inflammatory bowel disease.